Identifying Implementation Strategies for Emergency Department (ED) Delirium Screening in Older Adults

PROJECT SUMMARY/ABSTRACT
Delirium, or acute brain failure, affects up to 30% of older adults presenting to emergency care and is
associated with functional and cognitive decline, increased mortality, and billions of dollars in annual
healthcare costs. However, delirium is not detected in two-thirds of emergency department (ED) cases; we and
others have found that a minority of EDs (~14-22%) screen older adults for delirium. The ED environment,
characterized by high patient volumes, overcrowding, and parallel processing of patients with conditions of
varying acuity, can represent a challenging context for implementation of processes such as delirium
screening. This proposal uses an implementation science framework to identify strategies for successful
implementation of ED delirium screening. The ED is an important site for evaluation of delirium in an older
adult’s care trajectory, as early recognition of delirium in the ED may lead to improved prevention and
treatment, downstream health outcomes, and reduced costs.
The specific aims of this proposal are to: (1) use qualitative interviews with clinicians leading ED
delirium screening initiatives across the United States to identify barriers to and facilitators of implementation,
and (2) use rapid ethnographic assessment in one urban high-volume ED to identify strategies for successful
implementation of delirium screening within routine ED workflows. Together, these aims will generate novel
data about a breadth of approaches to ED delirium screening nationwide while also providing granular data
about ground-level implementation. This proposal is unique and innovative in its use of implementation science
frameworks and anthropological methods, which are well-suited to investigating healthcare delivery processes
in complex settings such as EDs. Furthermore, unlike other ED delirium research, which focuses on validation
of screening tools, this research will provide urgently needed information about strategies for successful
screening implementation.
Overall, this work will facilitate our long-term goal of promoting adoption and successful implementation
of ED delirium screening broadly in the United States. Practical implementation strategies for ED delirium
screening generated from this work will help refine our approach for a subsequent hybrid effectiveness-
implementation trial, which will be the subject of the applicant Dr. Chary’s future career development award to
the National Institute on Aging.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because identifying strategies for successful emergency department delirium screening implementation can facilitate early recognition of delirium, development of more effective prevention and treatment protocols, and reduction of associated morbidity, mortality, and health care costs. This research is relevant to the NIH mission because of its focus on processes to improve geriatric healthcare delivery while supporting the further training of Dr. Chary to become a leader in geriatric emergency care.